Identifying the Cognitive, Psychological, and Neuroimaging Signatures of Head Trauma in Female Survivors of Intimate Partner Violence

Statement of Work
A study coordinator is being hired for the current R01 award and was originally budgeted for 35
hrs/week. For the supplement we will increase this to 40 hrs/week to (up to a max of 640 hours
in years 2-4; and 600 hours in year 5). The coordinator will facilitate development of the FITBIR
upload protocol in year 1, then ensure all data are de-identified, reformatted for upload,
including using the GUID system for subject ID numbers. In years 2-5, the data coordinator will
de-identify all data, convert data to FITBIR formats, and upload de-identified data collected
across all sites to the FITBIR system semi-annually. The coordinator will also complete quality
and assurance to confirm that uploaded data is in correct formats and accurate.

Public health relevance
Narrative Physical trauma as an outcome of intimate partner violence (IPV) impacts an estimated 10 million people in the United States each year, with up to 90% of women exposed to IPV reporting episodes of abuse with head trauma. Women exposed to IPV are at a high-risk for developing mental illness and impaired cognitive function, which seems to be compounded in those with exposure to head trauma. This proposal aims to investigate the impact exposure to head trauma in IPV has on cognitive, psychological, and neural processes.